Analysis Core

The Analysis Core consists of experts with a broad range of complementary specialties, including
biostatisticians, gerontologists, sociologists, and demographers who are well known for aging studies. The
initial priority will be to support Texas RCMAR pilot studies in research design, measurement, and data
analysis. We will focus on the harmonization of measurements for cross-national studies and use of
longitudinal data from NIA-funded surveys to study the trajectory of physical function, cognitive function, social
support, frailty, disability, health care utilization, and survival among older Hispanics in the US and Mexico. In
addition, the core will consolidate the available national survey-Medicare linkage datasets and provide
expertise in analyzing these data sets to RCMAR scholars. Linking surveys to Medicare files will provide rich
information and resources for studying how social, psychological, economic, and behavioral factors impact the
trajectories of health care and health outcomes. The core resources will be available for any scholars
conducting research on Hispanics and other minority aging groups. The specific aims of the core are to:
1. Provide measurement, statistical and methodological support for pilot research designed to
increase the number of minority investigators conducting diversity aging research.
1.a. Participate in the design, monitoring, data management, and statistical analysis planning for pilot
research projects.
1.b. Provide analytical mentoring to RCMAR scholars.
2. Develop data resources, measurement, analytical approaches, and investigate the relationship
between social, psychological, economic, behavioral factors and health care and well-being in
longitudinal and cross-national surveys and survey-Medicare linkage data sets.
2.a. Documentation and dissemination of measurement protocols for measures used in Hispanic aging
datasets created by Texas RCMAR investigators.
2.b. Assistance in developing data use agreements and security protocols for use of Medicare data sets for
the studies of aging of Hispanics and other minority populations.
2.c. Coordinate data extraction and analytical file generation for aging investigators and provide statistical
consultation especially on the use of multilevel and longitudinal models for analysis of survey-
Medicare linkage data sets.
2.d. Adopt and develop innovative approaches in aging research.